Transovarial transmission of yersinia pestis in fleas

PROJECT SUMMARY
Flea transmission of human diseases has occurred throughout the world, the most notable of which is the
bubonic plague or black death, caused by Yersinia pestis. Although not the pandemic it once was, plague
continues to cause annual human mortality across four continents, including North America, where it is endemic
in the rodent populations of the rural western United States. In this region, flea transmission of plague occurs
annually among the large prairie dog populations which are abundantly distributed throughout the grasslands.
Due to its role as an ecosystem engineer and trophic relationship with the endangered black-footed ferret, there
is ample surveillance data on prairie dogs documenting widespread mortality caused by epizootic outbreaks of
plague. These outbreaks occur regularly, though not necessarily annually in a given area, and can substantially
impact the local ecosystem. Some geographic areas experience enzootic plague, characterized by prolonged
periods with little to no plague activity in wildlife in between epizootic events. Although there is more than 100
years of research on flea transmission of plague, there remain significant gaps in understanding the enzootic
cycle, even though this cycle underlies the global persistence of plague and its continued threat to public health.
The research proposed in this application addresses key factors that influence the enzootic cycle. Specifically,
the research will focus on redefining the role of transovarial transmission of Y. pestis as a driver of the sylvatic
plague cycle. The proposed project is built on strong preliminary data documenting transovarial transmission of
Y. pestis from laboratory-reared and infected Xenopsylla cheopis. These data suggest that bacteria that are
transmitted via this mechanism survive through all developmental stages and even grow in these environments,
which may indicate that transovarial transmission could impact the persistence of plague in the absence of
widespread mammalian disease. The proposed work will follow-up on these observations with an innovative,
state-of-the-art approach that incorporates high resolution transmission electron microscopy to examine bacterial
interactions within the midgut epithelium in order to identify the mechanism that may be used for dissemination
from the digestive tract to the reproductive organs of the flea. Furthermore, imaging of Y. pestis in each
developmental stage will be facilitated by the use of the Serial Block-Face Scanning Electron Microscopy
Volumescope (SBF-SEM) to reconstruct a high-resolution 3D image that illustrates the anatomical features that
support Y. pestis survival and growth in each life stage. The proposed work will rigorously address the potential
importance of this mechanism to the evolution and persistence of plague. Results of this high-risk, high-reward
R21 project will lay the groundwork for long term, inter-disciplinary mechanistic and ecological studies of
transovarial transmission of Y. pestis in fleas that will help inform our understanding of plague risk for humans
and animals.

Public health relevance
PROJECT NARRATIVE/ RELEVANCE Plague, caused by Yersinia pestis, is endemic in the Western US with potential to re-emerge as a deadly flea- borne zoonotic disease that can be transmitted from person-to-person. Although hundreds of years of research have led to a strong understanding of transmission and pathogenesis, there remains a lack of knowledge of the enzootic maintenance of Y. pestis and the factors that support an epizootic outbreak. This project addresses this gap by applying modern technologies to examine Y. pestis escape from the midgut and the potential for transovarial transmission to propagate infection in the flea vector thereby contributing to the enzootic maintenance of plague.